HORMONAL, VISUAL AND NEUROPHYSIOLOGIC DYSFUNCTION IN PATIENTS W/ PITUITARY TUMORS

The purpose of this protocol is to better define the hormonal, visual and cognitive dysfunctions produced by tumors, head trauma and other pathology in the pituitary hypothalamic area, determining the incidence, anatomical correlates, course and pathophysiology of such dysfunctions.